Imaging protease activation and maturation of single HIV-1 particles

HIV-1 is released from infected cells as an immature particle consisting of Gag and Gag-Pol polyproteins. At
some point during/after virus budding from the plasma membrane, the viral protease (PR) autoactivates by
cleaving itself off Gag-Pol and proceeds to cleave Gag and Gag-Pol at multiple sites and in defined order. This
sequence of well-orchestrated cleavage events culminates in the formation of a mature cone-shaped viral core
containing two copies of genomic RNA, nucleocapsid and viral enzymes, and surrounded by a lipid membrane.
Although the timely PR activation is critical for the formation of mature infectious HIV-1, the mechanism and
timing of PR autoactivation remain poorly defined. Recent studies revealed that inhibition of neutral
sphingomyelinase 2 (nSMase2), which converts sphingomyelin to ceramide, blocks HIV-1 maturation,
implicating lipids in regulation of PR autoactivation. We implemented and validated HIV-1 labeling and single
virus imaging approaches to visualize single virus assembly, PR autoactivation and substrate cleavage by total
internal reflection fluorescence microscopy. These approaches rely on FRET probes in which fluorescence donor
and acceptor are linked by distinct PR cleavage sites from Gag and Gag-Pol. We also established a correlative
light-electron microscopy (CLEM) workflow to link FRET substrate processing by PR to formation of mature
virions. Finally, we have developed a panel of innovative assays to characterize the properties of viral membrane.
Together, these technical advances put us in a position to elucidate the timing and regulation of PR autoactivation
leading to HIV-1 maturation. We propose three Specific Aims. Specific Aim 1 will measure the timing of PR
activation relative to HIV-1 scission from the plasma membrane. Using bifunctional FRET probes in which a
fluorescence donor also serves as a pH-sensor, we will visualize both single virus scission from a cell, by probing
the connectivity with the cytoplasm, and PR activation (loss of FRET signal). Specific Aim 2 will assess the
relative rate and extent of PR substrate cleavage in single HIV-1 and correlate these with formation of mature
virions. Specific Aim 3 will define the role of lipids in HIV-1 maturation by investigating the effects of nSMase2
inhibition on the properties of viral membrane and on Gag-Pol dimerization, which is believed to initiate PR
autoactivation. Collectively, the proposed studies will define the timing of PR autoactivation, elucidate the relative
rates of processing of distinct Gag and Gag-Pol cleavage sites, link surrogate substrate cleavage to HIV-1
maturation, and provide critical insights into regulation of PR activation by lipids. Knowledge of the mechanism
and regulation of PR autoactivation can inform new therapeutic strategies.

Public health relevance
Upon release from cells, Human Immunodeficiency Virus-1 (HIV-1) undergoes maturation which is initiated through autoactivation of viral protease that cleaves the structural proteins, Gag and Gag-Pol. The mechanism and timing of protease activation and its regulation by host and viral factors are incompletely understood. We will address these gaps in knowledge by incorporating novel fluorescent probes into virions and using advanced fluorescence and electron microscopy techniques to delineate dynamic processes underlying HIV-1 maturation.